Boston OAIC: A Translational Approach to Function Promoting Therapies

The Boston Older Americans Independence Center (Boston OAIC) has transcended the institutional
boundaries to forge an interdisciplinary research network among aging researchers from Boston's leading
academic centers to foster translational research in function promoting therapies (FPTs) – pharmacologic,
physical, nutritional, technological and behavioral interventions that reduce the burden of disabling functional
limitations. During its prior funding cycle, the Boston OAIC established 3 resource cores and supported 17
external projects, 9 pilot projects, 9 research education career (REC) awards, and 4 developmental projects.
These investments contributed directly to the advancement of several highly talented early career scientists,
including 3 Beeson awardees; enhanced research innovation and productivity, reflected in high quality peer-
reviewed publications; provided research core support to many NIH-funded innovative projects by OAIC
investigators; enabled substantial expansion of OAIC's collaborations with other Boston area aging centers
and with other OAICs; and spurred new technologies, inventions, and patents.
During the past cycle, the OAIC's center of gravity shifted to Harvard-affiliated medical centers due to the
relocation of the PI. With the inclusion of several Harvard geriatricians in its leadership, the Boston OAIC is
now well integrated with the Harvard Geriatrics and Gerontology research community and programs, including
its T32 training grant, Harvard Clinical Translational Science Institute, the Roybal Center, The New England
Geriatrics Research Clinical Education Center, and the Glenn Foundation Center for Biology of Aging.
During the next funding cycle, the Boston OAIC will maintain its thematic focus on FPTs and its positioning
across the entire spectrum of translational science from mechanism elucidation, preclinical proof-of-concept
studies, biomarker validation, epidemiologic investigation to randomized trials of FPTs. The OAIC’s research
program is founded on a platform of four cores: Leadership and Administrative Core (LAC), Research
Education Core (REC), Pilot and Exploratory Studies Core (PESC), and Resource Cores (RC). The OAIC will
integrate 19 externally-funded studies, and REC, PESC and developmental projects into a cohesive
interdisciplinary program that is supported by 3 resource cores: Function Assessment Core, Preclinical
Discovery Core, Biostatistics and Data Science Core. The REC will recruit the most promising stars from a vast
reservoir of talent at Harvard, Tufts and BU, and train them through didactic and mentored research programs.
The OAIC’s strengths include: 1) its focus on FPTs; 2) access to a large pool of talented young investigators,
especially physician scientists, including 3 Beeson scholars; 3) strong collaborative leadership which has
maintained high research productivity and grant funding; 4) strong institutional support; 5) success in
developing intellectual property; 5) supporting several seminal randomized trials of FPTs; and 6) its success in
forging synergistic collaborations with other Boston area aging research programs and with other OAICs.

Public health relevance
Narrative The Boston Older Americans Independence Center (Boston OAIC) has established a robust interdisciplinary research network among aging researchers from Boston's leading academic medical centers to foster translational research in function promoting therapies (FPTs) – pharmacologic, physical, nutritional, technological and behavioral interventions to reduce the burden of disabling functional limitations in older adults. The Boston OAIC will integrate 19 externally-funded studies, 3 Research Education Core projects, 3 pilot and exploratory science projects, and 3 developmental projects into an interdisciplinary program that is supported by a Leadership and Administrative Core, a Research Education Core, a Pilot and Exploratory Studies Core (PESC), and 3 research resource cores (Function Assessment Core, Preclinical Discovery Core, Biostatistics and Data Science Core). Unique strengths of OAIC include its focus on FPTs; emphasis on translation; demonstrable success in recruiting and advancing talented young investigators, especially physician scientists, including 3 Beeson scholars; its extension across the entire spectrum of translational research; the outstanding productivity of its investigators; strong leadership and institutional support; its success in developing intellectual property, leading and participating in some of the most important randomized trials of FPTs, and in forging synergistic collaborations with other OAICs and with other Boston area aging research programs.